Deciphering the role of the Cystic Fibrosis Transmembrane Receptor (CFTR) in dietary fatty acid transport in the small intestine

Program Director/Principal Investigator (Last, First, Middle): Kohan, Alison B (PI); Hodges, CA (MPI)
PROJECT SUMMARY
Though cystic fibrosis (CF) is considered a lung disease, it presents in infancy as an intestinal disease leading
to severe malnutrition and low body weight. These small intestinal symptoms are directly related to future
respiratory failure and mortality rates. A major gap in the field, even with modulator therapy, is determining the
mechanisms of intestinal CFTR dysfunction and how to reverse the persistent nutritional defects in patients with
CF. Using a novel surgical model and primary intestinal organoids, identified fatty acid (FA) trafficking across the
apical epithelial membrane as the step of lipid absorption that is inhibited by CFTR-/-. Our studies will test clinically
relevant experimental diets and modulator therapy in gold-standard models of fat absorption and use patient-
derived human intestinal organoids to directly quantify dietary fat absorption and chylomicron secretion. The
outcome of our studies could have a measurable impact on patients with CF, especially in early life, as these
studies will fill a persistent gap in knowledge about the activity of CFTR modulators in the intestine and
mechanisms of fat malabsorption (in CF and in other malabsorptive or diarrheal diseases).

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Kohan, Alison B (PI); Hodges, CA (MPI) PROJECT NARRATIVE Intestinal disease and fat malabsorption are the earliest manifestations of cystic fibrosis (CF) in children and are closely tied to deficits in growth and nutritional status, both of which are directly linked to respiratory failure and lifespan. We hypothesize that the cystic fibrosis transmembrane conductance regulator (CFTR), through its effects on intestinal pH and/or mucus, regulates dietary fat trafficking into intestinal cells which may be an overlooked contributor to metabolic disease in CF patients. Our studies are likely to impact potential treatment approaches to CF and will also uncover processes in normal fat absorption.